Multivalent mRNA HIV vaccine using Envelopes from recently circulating viruses.

ABSTRACT
Despite the advent of highly active anti-retroviral therapy, there are ~1 million new HIV infections and
hundreds of thousands of deaths annually. Thus, HIV is still a global health concern, and there remains an
unmet critical need for an effective vaccine to prevent HIV-1 acquisition. One strategy for an effective HIV
vaccine is to elicit broadly neutralizing antibodies (bnAbs) that target conserved epitopes on Envelope (Env) of
diverse HIV strains of different subtypes. Recent studies have shown that subtype C HIV-1 Env diversification
over time has resulted in greater resistance to nAbs and Fc-mediated antiviral activities, thus highlighting the
need for bnAb-inducing vaccine strategies to target recent subtype C viruses. However, there remains a gap in
our knowledge regarding the induction of bnAbs, including those that can target subtype C HIV Envs.
A common vaccination strategy for the development of bnAbs is the initial priming and subsequent boosting
or maturation of B cells that have the capacity to develop bnAb status with heterologous HIV neutralization
breadth. In this proposal, I will use a single priming Env immunogen followed by multivalent Env boosts to
mature V2-apex nAbs to bnAb status in a NHP model. My central hypothesis is that a V2-apex precursor B cell
engaging prime and multivalent boosting with computationally selected immunogens that captures the diversity
in the V2 region of recently circulating subtype C HIV, will engage and mature B cell lineages capable of
generating robust polyfunctional Env V2-targeting Abs that can neutralize heterologous HIV, including subtype
C Envs. The scientific premise for this project is that identifying vaccine immunogens capable of inducing V2-
targeting polyfunctional Abs that can recognize recently circulating viruses, including subtype C will provide a
much-needed component of a successful vaccine that can prevent HIV-1 acquisition.
At the completion of the proposed research, my expected outcomes are two-fold and related to: 1) scientific
achievements: development of an HIV-1 vaccine that elicits robust polyfunctional anti-V2 Ab responses against
subtype C Envs in an NHP model; and 2) career development: to gain knowledge and skills for leading a
preclinical and translational research program using NHP models to develop and test vaccines and
immunoprophylaxis strategies for HIV and other emerging/established pathogens.

Public health relevance
Project Narrative Despite the advent of highly active anti-retroviral therapy, there are 1.2 million new HIV infections and 630 000 deaths annually. This project will identify vaccine immunogens capable of inducing antibodies that will provide a much-needed component of a successful HIV vaccine.